Planning/Evaluation Core

PROJECT SUMMARY/ABSTRACT: PLANNING AND EVALUATION CORE
The Planning and Evaluation Core (PEC) will ensure that planning, monitoring, evaluation, and tracking of
partnership activities will be comprehensive to the needs of the Meharry Medical College/Vanderbilt-Ingram
Cancer Center/Tennessee State University Cancer Partnership (MVTCP), and utilize evaluation activities to
ensure that the MVTCP is successful in contributing to the broad goals of the Comprehensive Partnerships to
Advance Cancer Health Equity (CPACHE) program. The information we garner through our evaluation
processes will be used to guide the investment of resources into projects, programs, and institutional-level
strategies such as recruitment and leveraging of resources that support the goals of the partnership. At a time
in which cancer health disparities and inequities in research and education remain as major barriers to improving
health and quality of life for all, ensuring that the efforts of the MVTCP are successful is paramount. Conducting
high-quality, continuous evaluation of the MVTCP provides the opportunity to document our efforts, measure our
successes, and attend to our weaknesses for the purposes of program improvement. During the past funding
cycle, the PEC worked with all cores of the MVTCP to develop logic models that are used to identify program
theory, as well as the measurable outputs and outcomes of each core. The metrics identified through this process
were then harmonized with the CPACHE-wide evaluation indicators to create an integrated outcome framework
designed to capture the broader impact of the MVTCP. In the next funding cycle, we will build on this work to
develop evaluation tools and processes to ensure high-quality implementation of funded projects, integration
among projects and cores, and dissemination of methods and findings that demonstrate the impact of the
MVTCP. The work of the evaluation core will be guided by the following aims: 1) foster on-going coordination
facilitated by the Administrative Core, with the Internal Advisory Committee and Program Steering Committee to
ensure the MVTCP is receiving expert feedback and guidance on cores, projects, and the performance of the
MVTCP as a whole; 2) use a combination of established and innovative evaluation techniques to assess the
MVTCP and its accomplishment of short- and long-term goals; 3) develop a culture of evaluation within the
MVTCP that is committed to the use of data to support decision making, drive quality improvement, and inform
dissemination.